Radiochemistry and Molecular Imaging Probes

ABSTRACT
The Radiochemistry and Molecular Imaging Probes (RMIP) Core functions at the intersection of the
Cancer Center's laboratory research and clinical molecular imaging initiatives—including cancer biology,
medicine, chemistry, physics, radiochemistry, pharmacology, and engineering, and is one of the largest
manufacturing units at MSK in terms of the number of clinical and research products produced. The
RMIP Core was established to provide investigators with radionuclides and to incorporate these radionuclides
into radiolabeled diagnostic and/or therapeutic pharmaceuticals for both basic research investigations and
patient formulations. The RMIP Core consists of 5 major elements working closely together to provide the
following services: the Cyclotron Facility, the Small Molecule Radiochemistry Section, the Antibody
Labeling Section, the Development and Clinical Translation Section, and the Hyperpolarized Magnetic
Resonance Section.